Deconstructing brainstem circuits for visceral senses

PROJECT SUMMARY/ABSTRACT
The ability to tightly control metabolic homeostasis is critical for animal survival. The internal sensory nervous
system monitors the status of organs, providing feedback signals that enable the brain to maintain homeostasis
by executing behavioral and physiological responses. For example, the system detects and encodes
gastrointestinal cues signaling the quality and quantity of food ingested during a meal to control feeding behavior,
digestive physiology, and whole-body metabolism. Dysregulation of internal sensory systems that monitor the
digestive system can lead to various diseases, including obesity, diabetes, and anorexia. The internal sensory
gateway in the brainstem, the nucleus of the solitary tract (NTS), receives inputs from the gastrointestinal,
respiratory, and cardiovascular systems through the vagus nerve and other neural/humoral pathways. In turn,
the NTS projects to diverse higher-order brain regions to generate our perceptions of satiety, hunger, nausea,
and visceral pain. Despite the importance of internal sensory systems in health and disease, how neural circuits
process visceral signals to regulate behavior and physiology is vastly understudied. Disentangling the highly
interconnected brainstem neurons requires a comprehensive analysis of the anatomy, sensory coding, and
function of the NTS network to understand the circuit components that mediate individual visceral senses. In Dr.
Stephen Liberles’ lab, my initial postdoctoral work deciphered the sensory representations of bodily cues in the
NTS. In this proposal, the goal is to determine how internal sensory information, after being processed in the
NTS, is sorted into downstream brain regions to control specific aspects of behavior and physiology. First, the
neuroanatomical logic by which NTS projections are organized will be investigated (Aim 1). Second, visceral
cues transmitted by each projection will be determined using in vivo calcium imaging of NTS projection neurons
(Aim 2). Last, the functional roles of NTS projections in controlling behavior and autonomic physiology will be
established, with the focus on pathways that mediate physiological satiation (Aim 3). Research in this proposal
will be conducted under the guidance of Dr. Stephen Liberles, who pioneered the study of viscerosensory
neurons in the vagus nerve using genetic approaches, Dr. Clifford Saper, a leading scientist in the neuroanatomy
of the viscerosensory system, and Drs. Bradford Lowell and Eleftheria Maratos-Flier, experts in neural control of
appetite and energy metabolism. This proposal will establish a functional atlas of NTS projection neurons in
visceral senses, providing insights into our understanding of the neuro-circuitry underlying metabolic
homeostasis and strategies to develop targeted treatments for metabolic and viscerosensory disorders.

Public health relevance
PROJECT NARRATIVE The internal sensory nervous system maintains bodily homeostasis by monitoring the status of organs and controlling behavior and physiology. Using genetic tools to dissect neural circuits, I will determine the sensory properties and behavioral/physiological role of brainstem efferent pathways, focusing on neural control of appetite. This proposal will build a neuroanatomical and functional roadmap of the viscerosensory neural circuits in the brainstem, providing insights into developing targeted strategies for treating obesity, diabetes, eating disorders, and other diseases.